Viral and host determinants of donor-specific anti-HIV/SIV immunity mediated by APOBEC3-enzyme

PROJECT SUMMARY
Human APOBEC3 enzymes, particularly APOBEC3D, APOBEC3F, APOBEC3G, and stable haplotypes of
APOBEC3H, can induce G>A mutations in the HIV-1 genome. Often, these mutations, particularly those inflicted
by APOBEC3G, which is a potent anti-HIV enzyme, generate stop codons and lead to HIV-1 inactivation. Studies
have shown that APOBEC3 enzymes can also induce sub-lethal levels of mutations that lead to HIV-1
diversification and drug resistance. Mutations inflicted by different variants of APOBEC3 enzymes vary
substantially in terms of both their extent and sequence context. For example, APOBEC3H haplotype II often
induces many G>A mutations. By contrast, APOBEC3H haplotype I induces little or no changes in the HIV-1
genome. Analysis of all reported HIV-1 sequences from ~37,000 patients show that the extent and pattern of
viral mutagenesis by APOBEC3 enzymes are highly donor-specific. It is hypothesized that variations in both
APOBEC3 and HIV-1 genes are responsible for the observed differences in viral mutation profiles. The
preliminary data suggest these variations create a complex cascade of patient-specific interactions between HIV-
1 and APOBEC3 enzymes underlying HIV-1 health disparities including responses to antiretroviral treatments.
This proposal aims to integrate diverse viral and host datasets and use a combination of computational and
experimental techniques to identify the molecular determinates of differential viral mutagenesis, and elucidate
their roles in patient-specific responses to antiretroviral therapies.

Public health relevance
PROJECT NARRATIVE HIV mutations induced by human APOBEC3 enzymes can block viral replication or lead to drug resistance. Our data suggest that the processes involved in HIV mutagenesis are donor-specific. This project aims to identify the underlying genetic variations in both human and HIV using a combination of quantitative and experimental methods.